Healthy Cervix: A Clinic Community Health Educator-Based Cervical Cancer Education, Prevention and Screening Program (HEALIX)

PROJECT SUMMARY
Widespread use of the human papilloma virus (HPV) vaccine coupled with early detection is expected to reduce
the cervical cancer burden across all racial/ethnic groups and mitigate disparities as women of color are
disproportionately affected by cervical cancer. To address the current dearth of effective preventative programs
embedded within the community health clinic system, where most of the underserved populations receive care,
we developed the Healthy Cervix program, a community clinic health educator-based cervical cancer education,
prevention and screening effort, (“HEALIX”) built as a community engaged research collaboration between the
University of California, Davis Comprehensive Cancer Center and Peach Tree Health (Peach Tree), a Federally
Qualified Health Center (FQHC). HEALIX is grounded in a multilevel health equity framework merging a
community health worker-led outreach and education model approach with cervical cancer training for primary
care teams, and the option of both HPVself-collectionand clinical Papanicolaou (Pap) testing for clients/patients.
The primary goal of this study is to evaluate the acceptability, appropriateness, and feasibility of implementing
this multilevel intervention, which addresses individual, community, and systems level barriers, on increasing
HPV completion rates among patients ages 9-17 and Pap testing among women ages 21-65 in three of Peach
Tree’s clinics compared to usual care. This will be accomplished through the following aims: Aim 1) Customize
and contextualize cervical cancer prevention communications, education strategies and multi-media delivery
modes that will inform necessary adaptations to the proposed multilevel intervention; and Aim 2) Pilot the
HEALIX multilevel intervention in three Peach Tree clinics, evaluating selected implementation outcomes and
exploring service (screening/vaccination rates) and client/patient (satisfaction) outcomes.
The proposed research is significant because it will contribute to the field of multilevel intervention research to
mitigate cervical cancer disparities and addresses the need for more scientifically rigorous, evidence-based
interventions that can be disseminated and implemented in diverse communities. Successful achievement of our
Aims will significantly increase HPV vaccination and Pap testing rates over baseline, advance our understanding
of the utility of HPV self-collection kits in community settings; and will provide insights on strategies that can be
utilized to address other cancer health disparities impacting women. Furthermore, given the paucity of effective
multilevel interventions to increase HPV vaccine uptake and Pap testing in understudied, underrepresented, and
underreported communities, this study can guide effective dissemination and implementation of empirically
derived evidence-based interventions for health care delivery systems serving rural, racially/ethnically diverse,
and socially disadvantaged communities.

Public health relevance
PROJECT NARRATIVE Projections estimate that approximately 13,960 women in the U.S will be diagnosed with cervical cancer in 2023 and about 4,310 women will die from the disease, with most of these cases and deaths occurring among socially and economically disadvantaged women of color. Human papilloma virus vaccination coupled with early detection is the optimal primary prevention strategy against cervical cancer with potential to eliminate cervical cancer disparities. To address the current dearth of effective preventative programs embedded within the community health clinic system, we propose to prepare for and implement the Healthy Cervix (a.k.a. HEALIX) program, a community clinic health educator-based cervical cancer education, prevention, and screening effort, that addresses individual, community, and systems level barriers to achieve equity and eliminate cervical cancer.